MARC at the University of Florida

PROJECT SUMMARY/ABSTRACT
The proposed project addresses the problem of low diversity in biomedical and behavioral
research by continuing and improving the University of Florida (UF) MARC program. The
program will recruit 30 undergraduate trainees from underrepresented (UR) backgrounds and
place them with NIH-funded faculty mentors for up to three years of continuous research
mentorship within an integrated training environment. The overall program is designed to
increase each trainee's technical, operational, and professional development skills for
biomedical and behavioral research, promote each trainee's academic performance, and
enhance each trainee's mental health and wellness, with the goal of increasing motivation and
preparation for transitioning to a competitive PhD program. The program recruited its first
trainee cohort in 2017 and appointed 17 trainees through 2020 (four more have been selected
for 2021). All 12 trainees who have since graduated were accepted to competitive PhD
programs (10) or directly entered the biomedical workforce (2). The program includes 15
undergraduate degree programs at UF in which ca. 3,300 students (30%) are from
underrepresented racial/ethnic groups and ca. 1,000 (9%) are students with disabilities. The
proposed MARC program has six measurable performance targets: 1) recruit 30 trainees (10 as
rising sophomores and 20 as rising juniors), 2) at least 93% trainee retention, 3) 100%
participation in an extramural research experience, 4) at least 93% 4-year graduation rate (5-yr
for engineering majors), 5) at least 75% authorship on a research publication, and 6) at least
90% matriculation to a PhD or MD/PhD program within two years. The training plan includes
continuous participation in research mentored by a faculty research mentor and an integrated
curriculum of courses and activities. The proposed program includes three novel, innovative
projects: development of two Data Science and Research Computing courses that provide
training in biomedical applications of artificial intelligence and machine learning, biweekly
trainee participation Mental Health & Wellness Process Groups led by senior psychiatry
residents, and development of workshops to train graduate students and postdoctoral students
in mentoring undergraduates in research environments. Resources from these novel projects
will be open and exportable. Program outcomes will be continuously monitored, and
adjustments made whenever indicated.

Public health relevance
PROJECT NARRATIVE Diverse perspectives in biomedical and behavioral research lead to greater innovation and greater recognition of issues that continue to threaten the health, well-being, and inclusion of underrepresented (UR) communities. Consequently, increasing the diversity of biomedical and behavioral research scientists increases our potential to address the most urgent public health challenges, and is critical to the full realization of our national research goals. The proposed UF MARC program would recruit traditionally UR students who are considering a career as a research scientist, place them in mentored research environments with experienced faculty mentors, provide them with an integrated training curriculum to increase their technical and operational skills, and support their wellness and professional development through to their graduation with a BS degree and continuation to a competitive PhD program.